Using proteomics to identify host cell death factors during M. tuberculosis infection

Abstract
Infections from M. tuberculosis (Mtb) are a persistent global health threat. To develop therapies that augment
protective host immune responses against Mtb and shorten TB treatment, this proposal seeks to test our
central hypothesis that Mtb infection triggers autophagy factor phosphorylation that regulates host cell death
mechanisms. Understanding these regulatory mechanisms will enable the development of new host cell death
targets for Mtb treatment. In an unbiased phosphoproteomic analysis, we discovered Tax1bp1 (Tax1-binding
protein 1) and Optineurin were significantly more phosphorylated in Mtb- versus mock-infected bone marrow-
derived macrophages (BMDMs). Cytosolic autophagy receptors target pathogens for elimination by selective
autophagy, which inhibits necrosis. As phosphorylation leads to signal amplification and enables protein
function, we sought to test the role of Tax1bp1 and Optineurin during Mtb infection. As expected, we found
Optineurin restricts Mtb growth. However, surprisingly we found that Tax1bp1 enhances Mtb growth in most
cell types and during animal infection. Additionally, we found that the two autophagy receptors have opposite
impacts on host cell death. Tax1bp1 enhances early host cell necrosis and delays apoptosis whereas
Optineurin limits necrosis. To further determine how Tax1bp1 promotes necrosis during Mtb infection, here we
will investigate whether Tax1bp1 activates inflammasomes to cause pyroptosis, a programmed form of
necrosis. We will also test whether inhibition of the kinase that phosphorylates Tax1bp1 blocks Mtb growth and
necrosis. To elucidate whether Tax1bp1’s function in innate immune cells promotes Mtb growth in vivo, we will
take advantage of a new floxed Tax1bp1 mouse. To further test the function of Optineurin’s previously
unrecognized phosphosites in controlling host cell death, we will express Optineurin phosphomutant alleles in
macrophages for host cell death assays during Mtb infection. To identify additional phosphorylated host cell
death factors in other macrophage types relevant to Mtb infection, we performed phosphoproteomic profiling of
Mtb-infected primary human and murine alveolar macrophages (AMs). We identified five host cell death factors
phosphorylated in both BMDMs and AMs that are not already known to respond to Mtb infection involved in the
mTOR (mammalian target of rapamycin) pathway, which regulates autophagy and apoptosis. To test the
possible roles of these five host factors in cell death during Mtb infection, we will engineer knockout
macrophages for cell death assays. A better understanding of the mechanisms by which Tax1bp1, Optineurin,
and previously unrecognized host cell death factors impact Mtb pathogenesis may lead to the development of
host-directed therapies for TB infection that shorten the treatment duration.

Public health relevance
Narrative Infection from tuberculosis remains a threat to global public health, and new therapies are needed to shorten tuberculosis treatment regimens. In this proposal, we seek to understand how phosphorylated host autophagy factors impact host cell death during Mtb infection. A better understanding of the host defense pathways activated during Mtb infection may enable the development of host-directed therapies for tuberculosis.